One Ballroom: Understanding Intersectional Stigma to Optimize the HIV Prevention Continuum among Vulnerable Populations in the United States

ABSTRACT
Black and Latino trans women and men who have sex with men – or sexual and gender minorities of color
(SGMoC) - account for at least half of all new HIV infections in the United States (U.S.). At the same time there
is a significant disparity in knowledge of, access to and uptake of pre-exposure prophylaxis (PrEP) among
SGMoC is disproportionately low compared to white MSM and trans women. Numerous studies have articulated
disparities in HIV among groups under the SGMoC umbrella. However, most research aggregates experiences
based on one axis of stigma such as gay or trans identity. Intersectional HIV stigma, or stigma as the result of
multiple, intersecting minority identities, offer a complex lens in which to examine the multiplicative effect of
experiencing more than one axis of stigma. SGMoC face stigma as sexual, gender and racial/ethnic minorities.
SGMoC with these intersecting identities face racism, sexism, transphobia and a host of other stigmas that put
them at high risk of HIV and create barriers to HIV prevention. This study will include a 3-year in-depth
longitudinal qualitative phase, a 12-month longitudinal social epidemiologic phase, and an intensive
longitudinal ecological momentary assessment phase. We propose to use an innovative and culturally relevant
sampling strategy of web-based respondent driven sampling (webRDS) to recruit an online cohort of 900
SGMoC. The online cohort will complete 3 survey assessments in six-month intervals. The 200 highest risk
cohort participants will participate in EMA phase with to measure the immediate context of intersectional HIV
stigma, HIV prevention behaviors and HIV risk. These participants will receive short random ecological momentary
assessments daily for 30 days via a mobile health application. Not only will this study examine intersectional
HIV stigma in context of the daily lives of SGMoC, the ecological momentary assessment phase will also
inform future development of a context aware, ecological momentary intervention to reduce intersectional HIV
stigma and optimize the HIV prevention and care continua.

Public health relevance
PROJECT NARATIVE Getting to zero new infections in the US will require curbing the epidemic among Black and Latino trans women and men who have sex with men – or sexual and gender minorities of color (SGMoC). Intersectionality is an essential but underused framework in population health among SGMoC at elevated risk for HIV. The House and Ball Community (HBC) is a population that faces intersectional stigma and is underserved in the response to HIV. Research and interventions with the HBC have the potential to address intersectionality and transcend geographical boundaries to reach regions most impacted by HIV. Our proposal, One Ballroom, is a national mixed methods longitudinal population-based study of intersectional HIV stigma, and HIV prevention and care among SGMoC in the HBC. This study is the first step in a program of research that will lead to a stigma reduction intervention and includes a 3-year longitudinal qualitative phase, a 12-month longitudinal social epidemiologic phase, and an intensive longitudinal ecological momentary assessment phase.